Oregon BIRCWH K12 4th Scholar Supplement

Project Summary
This application is for an administrative supplement to the “Oregon BIRCWH: Scholars in Women's Health
Research Across the Lifespan” program to add an additional scholar from an Underrepresented Population in
the US Biomedical, Clinical, Behavioral and Social Sciences Research Enterprise. We are nominating Dr
Bethany Samuelson Bannow, Assistant Professor in the Division of Hematology, Knight Cancer Center,
OHSU, who has substantial consistent research productivity with an interest in uterine bleeding in patients with
hemostatic and bleeding disorders. She is committed to becoming an independently-funded clinician scientist
and thought leader in uterine hemostasis building upon her existing commitment to women's health and
sex/gender research. Her primary mentor will be Dr Alison Edelman, Professor of Ob/Gyn at OHSU, a clinician
scientist with a long track record in management of uterine bleeding, of NIH funding and mentorship. Dr Leslie
Myatt, Professor of Ob/Gyn, a basic scientist acknowledged for his record of NIH funding and leadership of
training programs will be secondary mentor and oversee training in advanced laboratory methods. Additional
accomplished mentors will provide subject specific expertise. A detailed career development plan, with specific
coursework, conference attendance and timelines is provided. The overarching goal of the Oregon BIRCWH
program is to recruit early-stage research faculty from diverse backgrounds and disciplines, and develop them
into scientific leaders who advance interdisciplinary research in women's health and sex/gender-based
research across the lifespan. The program provides: 1) a robust mentored research and training infrastructure
that promotes interdisciplinary women's health and sex/gender differences research; 2) a welcoming, diverse,
and inclusive culture of collaboration and mentorship that promotes team science; and 3) a proven process to
recruit, train, and support diverse faculty who become national research leaders and expand the footprint of
women's health and sex/gender differences research. The Oregon BIRCWH prioritizes the goal of gender,
racial, ethnic, ability, and sexual orientation equity and diversity in science, professional development, and
culture. Innovative expansions proposed in the recent renewal include: 1) enhancing our campus-wide
approach to recruitment and expansion of the BIRCWH infrastructure to attract, support, and nurture even
greater diversity; 2) drawing upon the legacy and success of the program to introduce a core curriculum
specifically tailored to the unique needs of BIRCWH Scholars, called “BIRCWH Essentials by BIRCWH
Alumni”; 3) leading inter-institutional conferences and events to promote innovative thinking, networking, and
collaboration; and 4) developing “BIRCWH Connect”, a social media platform to support an actively engaged
BIRCWH community across the country. The broad institutional support, highly interdisciplinary environment,
committed leadership, and deep dedication to diversity, equity and inclusion position the Oregon BIRCWH to
drive the future of women's health and sex/gender differences research for years to come.

Public health relevance
Project Narrative The Career overarching goa l of this administrative supplement to the Oregon Health & Science University BIRCWH Development Program is to foster the development of early-stage research faculty froman Underrepresented Population in the US Biomedical, Clinical, Behavioral and Social Sciences Research Enterpriseas a leader in women's health and sex/gender-based research across the lifespan. We apply the lifespan approach to faculty career development and science preparing BIRCWH Scholars to lead new initiatives advancing NIH ORWH research priorities.